DJ-1 and hexokinases

We have been interested in the relationship between oxidative stress and DJ-1, a rare cause of recessive Parkinson's disease, for several years and have focussed the relationship between oxidative stress and mitochondrial localization. In the past period, we have worked to understand how cells from patients with DJ-1 mutations react to mitochondrial damage. We used a series of isogenic lines with or without mutations to show that there are differences in mitophagy, liked representing a compensatory change in response to loss of DJ-1 expression.